Malignant Cell Engagement in Immune Circuits of Human Microsatellite-stable and Microsatellite-instable Colorectal Cancer

Project Summary
An important question in cancer immunology is how malignant cells and T cells communicate and impact the
efficacy of anti-tumor immunity. To generate hypotheses for how these cells interact, we have applied single
cell RNA sequencing to profile the transcriptomes of >700,000 malignant, immune, and stromal cells in 2
cohorts: (1) 65 patients with two types of primary untreated CRC (31 MSS and 34 MSI tumors) which are
characterized by vastly different immunotherapy response rates; (2) pre- and post-treatment specimens from
20 BRAF-mutant metastatic CRC patients treated with BRAFi/MEKi/anti-PD1. These data led us to formulate
the central hypothesis for this proposal: malignant cells that express interferon-stimulated genes (ISGs) acutely
promote anti-tumor immunity, while chronic interferon responses in malignant cells impair anti-tumor immunity
and therapeutic responses. The proposed work is anticipated to reveal fundamental insights into human tumor
immunology and provide a novel perspective for the design of robust biomarkers and new therapeutic
strategies. We will address three major questions. First, is the MSI/responder-associated ISG program in
malignant cells part of an intra-tumoral feed-forward loop that is driving anti-tumor immunity? This will be
answered by spatially mapping the intratumoral cellular interaction network between ISG+ malignant cells and
T cells in untreated primary CRC specimens, and in post-treatment specimens of patients treated with
BRAFi/MEKi/anti-PD-1, which will reveal association of this spatial network with tumor regression. Second,
what are the drivers of malignant ISGs in human CRC, and can interferons impact immune responses and
responses to targeted therapy by epigenetically reprogramming human CRC cells? To address this, we will
use interferons and innate immune stimuli to induce ISGs in CRC organoids, map the transcriptional and
epigenetic signatures to the signatures found in freshly isolated CRC cells, and nominate ISG-inducing
upstream regulators. IFN-stimulated and subsequently rested organoids will be assessed for epigenetic
memory and for modulated secondary immune and drug responses. Third, how do pre-existing ISG signatures
in malignant cells impact CTL-mediated anti-tumor responses? Using peptide-cognate T cell lines, we will test
the in vitro killing of ISG+ and ISG- peptide-loaded CRC organoids. We will furthermore test how ISGs
modulate in vivo tumor killing by temporally controlling malignant ISG expression in transplantable tumor
models. In summary, we use scRNAseq to predict malignant cell – T cell interactions, and then test these
hypotheses with cutting-edge technologies such as spatial profiling, single cell epigenomics, and human
organoid T cell co-cultures. The results should elucidate how malignant cells that respond to interferons impact
anti-tumor immunity and resistance, generate foundational results and model systems for an R01 proposal,
and prepare the candidate for an independent career to study the cellular networks that drive human tumor
immunity.

Public health relevance
Project Narrative Immunotherapy has shown impressive results in a subset of patients, yet solid tumors, including colorectal cancer, are often unresponsive and the underlying mechanisms are incompletely understood. The proposed research is expected to elucidate how productive anti-tumor immunity is coordinated in human CRC and solve long-standing questions regarding the seemingly conflicting effects of ISGs in human tumors. This knowledge has the potential to guide the design of better biomarkers and novel immunotherapy strategies, which is highly relevant to public health and NCI’s mission, given that colorectal cancer is the second leading cause of cancer- related death in the United States.